Mechanisms of Hair Cell Mechanotransduction Channel Gating

Project Summary
Auditory mechanotransduction channels reside at the tips of hair-cell stereocilia, where they mediate the
conversion of sound-induced mechanical stimuli into electrical signals that are transmitted to the brain. These
channels open in response to mechanical force and allow a selective influx of cations into hair cells. During
gating, a channel component is thought to undergo a particularly large conformational change - with an
estimated gating movement of ~ 4 nm. Their molecular identity has been pursued for over two decades. Recently,
we provided strong evidence that TMC1 forms the pore of the auditory transduction channels and bears
structural similarity to the TMEM16 family of ion channels. But we still don’t know how the channel works at a
molecular level. This is a fundamental aspect of hearing, as it underlies the conversion of sound into neural
signals by the mechanotransduction complex. The proposed research will integrate protein biochemistry,
molecular engineering, and hair cell physiology to probe the gating domains of TMC1. It will pave a path to
more extensive studies combining structural and functional biochemistry with single-cell physiology to provide
a comprehensive molecular characterization of how mechanotransduction channels open in response to force.

Public health relevance
Project Narrative Vertebrate hearing relies on the proper function of mechanotransduction ion channel proteins, which transduce mechanical stimuli into electrical signals that are transmitted to the brain. We recently showed that TMC1 is the pore-forming subunit of the hair-cell cochlear mechanotransduction channel, and proposed a structural model, but we still don’t know how tip-link tension induces a conformational change to open the pore. The aim of this project is to probe the gating mechanism of TMC1 using a structure-based mutagenesis approach, providing initial data for a more extensive structure-function study of how the channel works.